Determining mechanisms of bone remodeling response to high metabolic demands of aerobic exercise

Abstract
Exercise is an important modulator of human health, and mechanical loading during strength and resistance-
based exercise is well known to positively impact bone mass by enhancing osteoblast-mediated bone
formation. However, there is a fundamental gap in understanding the response of bone to aerobic metabolic
demands found in activities like running and cycling, and how those demands interact with the mechanical
loads placed on the skeleton during exercise to differentially modulate bone mass. Emerging evidence shows
that aerobic exercise induces acute elevations in the bone resorption marker carboxy-terminal telopeptide of
type I collagen (CTX) without compensatory changes in bone formation, suggesting an immediate and
unexplained pro-resorptive response. While well-documented, there is substantial lack of prior rigor regarding
the cell source, extent, and purpose of elevated bone resorption during aerobic exercise. These questions are
important because they may help facilitate the development of more precise recommendations for aerobic
exercise to modulate bone health. Furthermore, they may provide greater understanding of factors governing
bone loss in conditions of high metabolic demands or low energy availability that often result in fractures or
additional disability in vulnerable populations. The central hypotheses of this proposal are that the source of
CTX elevation during exercise exists on a spectrum between osteocyte perilacunar remodeling (PLR) and
osteoclast resorption, the extent of which is governed by energy demands during exercise, and that CTX
elevation is proportional to amino acid flux into skeletal muscle. These hypotheses will be tested in three
distinct, non-overlapping specific aims. Aim 1 will determine the source of elevated CTX during aerobic
exercise. We will selectively inhibit osteocyte perilacunar remodeling using MMP13ocy-/- mice and compare
exercise-induced elevations in CTX to mice treated with pamidronate, which we have previously shown can
inhibit osteoclast activity in the face of sustained PLR, or cathepsin K inhibitor, which selectively inhibits
collagen degradation, but not demineralization of the bone ECM. Aim 2 will determine the relationship between
CTX elevation and energy demands during exercise. We will run well-trained human subjects, and rats bred for
high and low aerobic capacity, at treadmill speeds correlating with varying oxidative and non-oxidative energy
demands. Subjects will run on commercial (human) and custom (rat) treadmill-interface systems to uncouple
metabolic demands from biomechanical loading, and we will further modulate energy demands in the presence
or absence of carbohydrate supplementation. Lastly, Aim 3 will evaluate the relationship between CTX
elevation and amino acid distribution to skeletal muscle during aerobic exercise. We will assay circulating and
muscle-targeted amino acids in rodent samples to quantify amino acid flux to the muscle in relation to both
modulation of bone turnover and energy demands of the exercise itself.

Public health relevance
Narrative: The proposed research aims to understand how the skeleton responds to the high metabolic demands of aerobic exercise, with a focus on the role of osteocyte perilacunar remodeling and osteoclast bone resorption. These studies have important implications for public health, as they could improve our understanding of bone loss in other conditions of high metabolic demand or low energy availability. Additionally, these outcomes will lay the foundation for future studies to facilitate the development of targeted interventions to optimize bone health through aerobic exercise across a variety of populations.